Spermatogonial Stem Cell Establishment and Regulation

Spermatogonial stem cells (SSCs) are self-renewing cells essential for adult spermatogenesis that hold promise
for treating male infertility. In this proposal we focus on two topics revolving around SSCs. First, we will identify
“transcription factor (TF) circuits” critical for SSC establishment. Identifying such TF circuits will allow us to
ultimately define a functionally defined (not merely “omics” defined) TF network that drives immature germ cells
to become stem cells. Second, we will follow-up on our surprising finding that knockout (KO) of a transcription
factor important for spermatogenesis causes expansion of SSCs. Understanding the underlying mechanism for
this potential compensatory response to genetic insult has the potential to reveal insights into how human SSCs
respond to toxic insults and infertility.
The molecular mechanisms by which SSCs are initial generated in vivo are poorly understood. One of the few
proteins that have been shown to drive SSC establishment is the homeobox TF, RHOX10, which we showed
promotes SSC precursor cell differentiation and the initial seeding of SSCs in the seminiferous epithelium. Given
that TFs are regulatory factors that control batteries of downstream genes, our discovery that RHOX10 drives
SSC establishment provided an opportunity to define key genes critical for this process. Indeed, we recently
identified scores of direct RHOX10-target genes, including a remarkably large number of TF genes with known
roles in SSCs. This led us to hypothesize that a TF network is critical for SSC establishment, which we propose
to test. This is critical, as even though other studies have identified hundreds of downstream genes regulated
by TFs at various germ cell stages, it has not been ascertained which of these downstream genes are functionally
important for the action of a given TF. In Specific Aim 1, we will perform functional experiments to determine
the regulatory relationships of TFs, thereby allowing us to define functional TF circuits. As evidence of feasibility,
we recently defined—through rescue experiments—3 TFs that function in a TF circuit to drive SSC precursor
cell differentiation. The other focus of this proposal revolves around our unexpected recent discovery that adult
Rhox10-null mice have expanded numbers of SSCs. Understanding the mechanisms that drive SSC expansion
is critical for devising approaches to treat infertility. Our preliminary data support 3 testable models to explain
the SSC expansion in these KO mice, including a compensatory mechanism model in which SSCs undergo
proliferative expansion when they sense downstream spermatogenic defects. In support of such a feedback
mechanism operating in humans, it was recently reported that cryptozoospermia infertility patients have a
selective and robust increase in the number of SSCs, as defined by single-cell RNAseq analysis. In Specific
Aim 2, we will determine the cellular and molecular mechanisms responsible for the expansion of SSCs in
Rhox10-null mice. Elucidating mechanisms controlling SSC expansion in vivo has the potential to translate into
approaches into expanding SSCs in vitro for clinical applications.

Public health relevance
Narrative Male infertility is extremely common (affecting >100 million men world-wide) but in most cases the underlying mechanism is not known and there are no direct treatment options. This application is focused on spermatogonial stem cells (SSCs), which hold promise for correcting many cases of male infertility. The experiments proposed in this application are designed to understand fundamental mechanisms underlying both SSC development and expansion, as key steps towards the goal of developing SSC therapy for treating infertility.